Translating Genetic Risk Factors to Therapies: From Big Data to Druggable Targets

PROJECT SUMMARY
Genome-wide association studies (GWAS) provide insight to underlying etiologies of disease not obvious
through clinical evaluation or pathophysiology alone. Genetic variants associated with complex, often refractory
diseases such as Alzheimer’s Disease (AD) and Multiple Sclerosis (MS) may hold the key for the next generation
of treatment options. Leveraging genetic data with current standards of care and known pathophysiology can
provide a strong premise for mechanistic studies and novel drug targets. My current work studies the molecular
genetics of CD33 in AD under Dr. Steve Estus. CD33 normally acts to inhibit microglial activation in the brain,
suppressing amyloid clearance. We are investigating how the AD-protective single nucleotide polymorphism
(SNP) in CD33 modulates protein, and thereby cellular, function. This SNP leads to an increase in an alternative
CD33 protein isoform which, based on our recent genetic data, may promote—rather than suppress—microglial
activation. I will learn new technical skills during the F99 phase of this award, and I will use these skills as I switch
focus to MS and progress into the K00 phase to acquire additional, powerful techniques and models including
work with patient samples, pluripotent stem cells, single-cell sequencing technologies, and animal models.
In Specific Aim 1, I detail how my training in molecular biology and genetic concepts has allowed me to
conceive independent hypotheses and carry out complex experiments. My doctoral work on the molecular
genetics of CD33 and its association with reduced AD risk has provided training in GWAS interpretation,
quantitative PCR, immunoassays such as Western blotting and co-immunoprecipitation, and genetic techniques
including transfection and genome editing strategies in cell culture. In Specific Aim 2, I will continue to develop
as a scientist and finish my doctoral work, carrying out increasingly complex studies to include high-resolution
confocal imaging and subcellular localization, measuring time- and dose-dependent protein phosphorylation in
situ, gene expression arrays, and functional assays including phagocytosis in vitro. I will also continue developing
my professional skills such as oral and written communication, networking, and mentorship. In Specific Aim 3, I
will extend my doctoral training to include work with human tissue samples and mouse models of MS. I
have not yet identified a specific postdoctoral mentor, but my ideal mentor will have experience conducting
human subjects research, using mouse models of MS, and have a strong track record of training fellows to
become tenure-track faculty. I will identify a mentorship team to guide my technical and professional
development during this phase. I will leverage my current training in molecular genetics to identify MS-associated
functional SNPs, my training-in-progress to identify the mechanism behind these SNPs at the protein and
intracellular signaling levels, and my future training with murine models and human subjects to establish a high-
impact, translational career, combining genetic, clinical, and pathology findings for pharmacological
breakthroughs in neuroimmune diseases.

Public health relevance
PROJECT NARRATIVE Genome-wide association studies of human disease provide a powerful opportunity to uncover novel etiologies and inform rational drug targets which would otherwise be overlooked. The goal of this project is to elucidate the mechanism whereby a genetic variant in CD33 protects individuals from Alzheimer’s Disease, which may provide a breakthrough in this devastating disease with no effective treatment options and improve the quality of life for millions of patients. This project will provide exceptional training to an underrepresented and highly motivated doctoral candidate, facilitating his transition to postdoctoral studies and launching his promising career as an independent neuroscience researcher.